Summer Training in Translational Biomedical Research

Project Summary
The Summer Research Training Program at the College of Veterinary Medicine at the University of Illinois seeks
to identify and facilitate the career progression of veterinary students who have the ability and motivation to
become veterinarian medical scientists. The veterinary perspective has high value in biomedical research and
there is a relative shortage of veterinarian scientists. Thus, the goals of this veterinary student training program
are to help trainees understand the research process, gain research experience, learn scientific communication
skills, and identify career opportunities and training pathways. The focus of this training program is translational
biomedical research, broadly encompassing the research areas of infectious diseases, reproductive biology,
epidemiology, neuroscience, oncology, toxicology, nutrition, and behavior. The productive and collaborative
program faculty include 37 mentors from 11 different academic departments in five colleges. The 10-week
program is open to veterinary students who have completed one or two years in the professional curriculum. A
total of ten trainee positions are available each program year. Trainees are matched with a faculty mentor who
shares similar research interests. In collaboration with the faculty mentor, trainees formulate a testable
hypothesis, design the experiments, collect and analyze the experimental data, and report the conclusions.
Reporting of results includes authoring an abstract that is submitted to a national meeting, preparing a poster
presentation of the work, and writing a short manuscript formatted for a scientific journal appropriate for
publishing the results. Extensive instruction in the Responsible Conduct of Research and Reproducibility and
Rigor is provided through orientation week activities and a weekly seminar series. The seminar series also
features presentations that highlight career opportunities available to veterinarian medical scientists, field trips
to companies that hire veterinarian medical scientists, and an annual symposium with veterinary trainees and
faculty from Purdue University. Scientific writing sessions are provided to assist trainees with preparation of the
abstract, poster, and manuscript. At the conclusion of the program, trainees present their work at an in-house
poster session and at the National Veterinary Scholars Symposium. Follow-up engagement over the course of
the student’s DVM training and beyond provides support and mentoring to continue to develop research
experience and the potential to pursue a veterinarian-scientist career.

Public health relevance
Project Narrative This 10-week summer research program will train the next generation of veterinarian-scientists in biomedical research. This program will help a diverse population of veterinary students understand the scientific process, gain research skills, learn scientific communication skills, and identify career opportunities and training pathways. Training future generations of veterinarian scientists is essential for advancing society’s understanding of the biomedical sciences and promoting public health.